The role of lysosomal impairment in trichloroethylene induced Parkinsonian neurodegeneration

Parent Project Summary
Parkinson’s disease (PD) is a systemic, progressive neurodegenerative movement disorder and type of
synucleinopathy characterized by the presence of misfolded α-synuclein (αSyn) protein aggregates (Lewy
bodies). The majority of PD etiology is not well explained by inherited genetic risk variants, and conversely, is
strongly tied to exposure to environmental contaminants, particularly industrial byproducts such as pesticides,
metals, and organic solvents. Data from our lab indicates that exposure to environmental toxicants associated
with PD risk impairs the autophagy-lysosomal pathway (ALP), causing aberrant proteostasis and cellular
dysfunction that influences disease development. Furthermore, new data suggests that the PD associated
genetic risk factor and kinase protein LRRK2 plays a key role in lysosomal homeostasis, which implicates the
lysosome as a convergence point for genetic and environmental risk factors in PD.
The chlorinated organic solvent trichloroethylene (TCE) is associated with 2-6 times elevated risk for PD,
however, the mechanisms by which this occurs remain vastly understudied considering the pervasiveness of
its environmental contamination. We previously showed that exposure to TCE induced endolysosomal deficits,
endogenous αSyn accumulation, and dopaminergic neurodegeneration in adult rodents. We also observed that
TCE elevated the kinase activity of wildtype LRRK2 in the brain. In line with this, we have new preliminary
evidence that TCE exposure causes loss of lysosomes, reduced proteolysis in dopaminergic neurons and
significantly worsens αSyn preformed fibril (PFF) accumulation in brain tissue of adult rats. Thus, we
hypothesize that an important mechanism of TCE is disruption of lysosomal function, leading to
proteostasis impairment and neurotoxicity that triggers or facilitates PD development.
This proposal is designed to uncover the mechanisms of TCE-induced lysosomal impairment, aberrant
proteostasis, and dopaminergic neurodegeneration associated with PD risk. To do this, we will use our novel,
environmentally relevant TCE inhalation model to measure how the solvent modulates αSyn PFF aggregation
within the rat brain (Aim 1), and if loss of lysosomal function in central and peripheral neurons using newly
developed Thy1-RFP-GFP-LC3 transgenic mice correlates with αSyn seed amplification signal measured via
RT-QuIC (Aim 2). Last, we will assess how TCE-induced LRRK2 kinase activation influences lysosomal
function and if pharmacological inhibition of LRRK2 prevents lysosomal impairments and neurodegeneration
induced by TCE (Aim 3). Together, these experimental aims support a fundamental new mechanism in the risk
for PD and related synucleinopathies from environmental factors and advances the NIEHS strategic plan to
improve human health though environmental exposure research.

Public health relevance
Project Narrative This is a request to support Dr. Allie Smith through the NIEHS program “Research Supplements to Support Diversity in Health-Related Research” (PA-23-189) under Dr. Briana De Miranda’s (PI) award R01ES034846. Allie is a postdoctoral fellow in Dr. De Miranda’s lab at the University of Alabama at Birmingham. The studies outlines in this proposal will extend the parent grant to include investigations into early life exposures of trichloroethylene (TCE).